Inheritance and Reprogramming of Maternal Chromatin during Zebrafish Maternal Zygotic Transition.

Project Summary/Abstract:
Inheritance and Reprogramming of Maternal Chromatin during Zebrafish Maternal Zygotic Transition
Zygotic genome activation (ZGA) is a pivotal event during the maternal-to-zygotic transition (MZT), the
developmental period shortly after fertilization when gametic genomes undergo reprogramming. Epigenetic
reprogramming of the parental genomes is essential to prepare the zygotic genome for transcription activation.
Additionally, the localization of transcription machinery such as transcription factors and RNA Polymerase II to
zygotic genes plays a crucial role in their precise transcriptional activation. However, it has remained unknown
how maternally provided transcription repressors function to prevent precocious zygotic transcription activation
prior to ZGA. Using the genomic and molecular approaches, we have discovered certain loci may function as
transcription repressors potentially via sequestering transcription machinery including transcription factors and
RNA Polymerase II from developmental genes. During the lead-up to ZGA, the chromatin accessibility at these
loci is drastically decreased and this decrease coincides with increased accessibility and subsequent nascent
transcription at developmental genes. I also found that the decrease in accessibility of these loci is associated
with heterochromatin establishment at these loci. I hypothesize that specific loci function as a sink and
sequester transcription machinery including RNA Polymerase II to silence zygotic gene transcription until the
epigenetic repression of these loci leads to the release of RNA Polymerase II to drive nascent transcription at
zygotic genes. Using a combination of genomic, molecular, and imaging approaches, I will use mutants that
inherit these loci with accessibility lower than that in wildtype and mutants that fail to silence these loci at ZGA
to investigate their functions in the regulation of ZGA timing. These studies would demonstrate
transcription machinery sequestration as a novel mechanism of ZGA regulation.

Public health relevance
Project Narrative After fertilization, zygotic genome activation is a critical process that enables the transition from maternal program to zygotic program. Better understanding of the mechanisms underlying zygotic genome activation has important implications for fertility treatments and maternal-fetal health. This proposal will investigate how maternally provided DNA and proteins may regulate the accurate timing of zygotic genome activation.